Leveraging canine spontaneous cancer to optimize the power of blood biopsy

PROJECT SUMMARY
Recent technological advances have driven the development of novel, less invasive approaches for assessing
the tumor genome. In particular, the “blood biopsy” which leverages circulating tumor DNA (ctDNA) released by
dying cancer cells, has potential utility for screening individuals at risk for cancer, determining those patients
likely to relapse post treatment, identifying actionable mutations to plan treatment and characterizing tumor
genome evolution. However, several challenges remain including the need to standardize collection and
processing procedures, optimize sequencing/analysis platforms, and correlate data generated from ctDNA with
patient outcomes. For example, factors such as time of day or vein used for blood collection (central vs.
peripheral) may influence ctDNA yields and reproducibility of the assay. Moreover, while evaluation for common
mutations can readily be performed using ctDNA (i.e., EGFR mutations in lung cancer), tumor types with low
mutation burden and/or large structural variants (deletions/inversions) remain more difficult to characterize.
Finally, prospective sampling of human patients to assess the predictive value of blood biopsy requires a
relatively long timeline (years). While such studies would presumably be ideal in murine cancer models where
disease progression is rapid, blood volumes are limited, repeated sampling can be difficult, and it is problematic
to accurately recapitulate cycles of treatment response and resistance. Interestingly, pet dogs spontaneously
develop cancers that closely mirror their human counterparts with respect to clinical course, molecular
dysregulation and genomic alterations, and as such they represent a unique model for improving blood biopsy
performance and application. Because pet dogs receive standard treatment (chem/radiation/immunotherapy) yet
experience a compressed disease timeline, critical information can typically be obtained quite rapidly. Toward
that end, we have generated preliminary data demonstrating that ctDNA is readily detectable in dogs with cancer,
that genetic changes concordant with those in the tumor can be detected, and that treatment has a variable
impact on ctDNA levels. The purpose of this proposal is to build upon these findings to credential dogs
with cancer as a relevant tool for blood biopsy advancement and use this model to optimize and advance
its application to human patients. Specifically, we will determine how various factors affect ctDNA yield,
assess concordance of tumor and ctDNA sequence data, develop and implement a diagnostic mutation panel
for patient screening, and conduct longitudinal studies to track both minimal residual disease and likelihood of
relapse. To facilitate rapid clinical translation of findings, we selected canine cancers with genomic landscapes
that have human equivalents: urothelial carcinoma (BRAF V595E), mast cell tumor (KIT internal tandem
duplication), osteosarcoma (large structural variants), lymphoma (Myc amplification, TRAF3 mutation) and
hemangiosarcoma (p53, PIK3CA mutation). Tools created through this work will have utility for ongoing as well
as future canine translational cancer research, thereby supporting continued development of this model system.

Public health relevance
PROJECT NARRATIVE Over the past decade, technologies that enable precision medicine have markedly improved, enabling the detection and analysis of a variety of soluble biomarkers, now referred to as the blood biopsy. In particular, assessment of circulating tumor DNA (ctDNA) is increasingly being used for therapeutic decision-making in cancer patients; however, several challenges remain before this approach can be effectively implemented to truly advance treatment and prevention outcomes. The purpose of this grant application is to leverage the spontaneous canine cancer model to optimize a set of novel tools and methodologies for ctDNA based blood biopsy that facilitate early screening, minimal residual disease monitoring and interrogation of tumor genome evolution, with the goal rapid translation to human oncology.